Sleep health in special populations

PROJECT SUMMARY
Insufficient and poor quality sleep resulting from sleep disorders can have a negative impact on health
outcomes and quality of life. This is particularly true for patient populations who are at risk for poor outcomes
due to comorbidities. While there are established treatments and best practices for management of sleep
disorders, including sleep apnea and insomnia, significant knowledge gaps remain in how best to manage
complex patients and improve patient-centered outcomes. The goal of this application is to provide support for
mentoring of trainees and junior investigators in the areas of sleep disorders and sleep health among patient
populations who are “at risk.” The applicant's current research program focuses primarily on women with sleep
apnea, who are at elevated risk for non-adherence to PAP therapy compared to men, particularly when they
face additional challenges to adherence, such as psychiatric comorbidities. The main research aims of the
funded work focus on improving adherence to PAP therapy among women. Additional aims focus on improving
PAP adherence among patients with spinal cord injuries and on implementing practices to improve sleep in
long term care settings. Dr. Martin has a track record of mentoring trainees at multiple levels toward research
independence, and the proposed award will enhance her ability to provide additional mentoring in patient
oriented research focused on sleep disorders and sleep health. The goal of the award is to increase the
number of independent clinical investigators studying how best to treat patients with sleep disorders in “real
world” settings. As such, the goals of the proposed training plan focus on providing Dr. Martin with training in
implementation science. UCLA and the VA Greater Los Angeles Healthcare System (VAGLAHS) provide rich
environments for mentoring and for applied clinical and health services research. Finally, development of web-
based resources for clinical trainees in patient oriented research will be developed for use within and beyond
UCLA and VAGLAHS.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The proposed work will support Dr. Martin's mentorship of early-career clinical researchers in patient oriented research related ot sleep health in special populations. The protected time and additional resources provided by this award will allow her to expand her successful research mentoring program, develop web-based training in patient oriented research for clinical trainees, and dedicate time to additional training in implementation science. The program will benefit from Dr. Martin's ongoing program of patient-oriented research focused primarily on women's health and sleep, and from the resource-rich environment at UCLA and VAGLAHS.